Cellular stress sensing via biomolecular condensation

Project Summary
Background: Cells experience a wide array of environmental stresses, and must be able to sense and respond
to changes in order to survive. The sensing process which occurs depends on the stress itself, and we have
identified over 150 heat-sensitive proteins in S. cerevisiae which exhibit biomolecular condensation after
temperature increase. Within this group, a conserved set of GTPases displays significant aggregation without
the requirement of any other cellular components, opening up the possibility that these proteins have the ability
to sense heat shock. Further, this set of proteins is connected to two fundamental functional responses which
occur under heat stress -- transcriptional upregulation of heat shock genes and shutoff of ribosome biogenesis.
Proteins that are highly sensitive to heat may act as long-unidentified sensors upstream of massive functional
changes within the cell, and serve as heat sensing candidates for this proposal.
Long viewed as a toxic consequence of harsh environmental conditions, recent work has shown that
biomolecular condensate formation is non-random, adaptive, and reversible. With this emerging view, diseases
like dementia and ALS which are associated with the accumulation of non-membrane bound protein aggregates
might be the result of an aberrant activation of stress sensing pathways, indicating that our understanding of the
disease pathology may need to be reevaluated.
Specific Aims: 1: Are candidates sufficient to induce the transcriptional response in vivo? 2: What is the
mechanism for heat sensing? 3: What is the functional relevance of candidate condensation on ribosome
production?
Study Design: I will take advantage of a cryophilic yeast which execute their heat-induced cellular responses at
lower temperatures than S. cerevisiae. The cryophilic yeast likely contain homologous sensor proteins with
increased sensitivity at lower temperatures. I will replace the endogenous sensor candidate genes with their
cryophilic homologs and assay the ability of the recombinant S. cerevisiae to upregulate the production of heat-
specific transcripts and attenuate ribosome biogenesis. I will reconstitute the components of these functional
responses in vitro and test whether the condensation of candidate sensors can affect either response.
Condensation of candidate sensors will also be studied in vitro using biochemical and biophysical assays to
investigate their intrinsic ability to sense heat to describe the mechanistic underpinnings of sensing.
Training: This research will be performed with Dr. D. Allan Drummond at the University of Chicago and will build
upon my experimental skills by first characterizing the functional relevance of biomolecular condensation in
environmental stress sensing and further expanding into understanding the biophysical mechanism. This training
will prepare me for a future career studying how environmental stresses shape cellular behavior.

Public health relevance
Project Narrative Primordial environmental stresses such as heat, hypoxia, and nutrient deprivation trigger protein aggregation, thought to be toxic, which induces a stereotypical set of responses across the tree of life. Recent work suggests that this stress-induced aggregation may instead reflect the formation of biomolecular condensates as part of an adaptive response to stress, with important consequences for our understanding of aggregation-associated diseases such as dementia and ALS. This proposal investigates specific examples of biomolecular condensation which are environmentally sensitive and positioned to regulate conserved cellular responses.